ASYMPTOMATIC CARDIAC ISCHEMIA PILOT STUDY

To determine the relative efficacy of symptom (angina) directed therapy, angina guided lplus ambulatory electrocardiogram guided medical therapy and mechanical revascularization to provide freedom from myocardial ischemia.